Cancer Center Administration

PROJECT SUMMARY – CANCER CENTER ADMINISTRATION
The Ohio State University Comprehensive Cancer Center (OSUCCC) Administration provides efficient and
effective administrative support to the OSUCCC’s Director, Senior Leadership, Research Program Leaders,
Shared Resource (SR) Directors and OSUCCC members. The role of OSUCCC Administration is to
operationalize OSUCCC’s most critical research functions by fulfilling the following Specific Aims: 1) Accelerate
OSUCCC’s remarkable evolution by leveraging resources and expanding OSUCCC’s infrastructure; 2) Promote
OSUCCC’s strategic planning and evaluation efforts; 3) Support OSUCCC’s comprehensive basic science,
clinical and cancer control activities by fostering transdisciplinary and/or translational science; and 4) Support
OSUCCC’s community outreach and engagement and education and training activities. The OSUCCC is a matrix
cancer center with administrative staff providing support to 293 OSUCCC members from 48 departments in 11
Ohio State University colleges, with 108 members recruited in the last five years. OSUCCC Administration
leverages the expertise of its team members while operating in an innovative and efficient manner. New initiatives
supported since the last grant cycle include: 1) developing the OSUCCC Pelotonia Institute for Immuno-
Oncology (PIIO) in partnership with Pelotonia, a major donor providing $65M for the PIIO; 2) supporting an
increase of direct cancer-related research funding from $64.8M to $75.4M between 2015-2020; 3) facilitating
recruitment of key senior-level faculty; 4) enabling the seamless transition of a new OSUCCC Director and
supporting advisory committee restructuring; 5) providing full support for 18 PPG, 6 SPORE and 14 other large
multi-investigator (e.g., UG1, UM1, U19, U54) applications resulting in six funded awards; 6) supporting the
development of the Small Animal Imaging and the Clinical-Translational Science into full SRs in this application;
7) initiating two developing SRs (Targeted Validation and Gene Editing); 8) fostering growth of the Clinical Trials
Office from 130 FTE to 189 FTE to facilitate clinical research; 9) completing the entire fit-out and full occupancy
of over 1.18M ft2 of space in The James Cancer Hospital and Solove Research Institute which opened in
December 2014; 10) overseeing expansion of research space including new space for the OSUCCC Center for
Tobacco Research; 11) working with University leadership to obtain 100,000 ft2 dedicated for cancer research;
two floors will be in the new Interdisciplinary Research Facility, scheduled to open in 2023; 12) creating
CAMELOT (Center for Cancer Mentoring, Education, Leadership, and Oncology-related Training) to centralize,
coordinate and manage all cancer education and training activities; 13) facilitating development of Ascending
to New Heights, the 2020-2025 OSUCCC Strategic Plan; 14) implementing eRAMPv2, an OSUCCC online
ordering and billing system, across SRs; 15) deploying $15M for new pilot grant opportunities; and 16) promoting
research-relevant communication throughout the OSUCCC catchment area through additional social media
platforms, cancer-focused symposia and development of a new website.